Life-course, exposomics, and analytic program (LEAP) in Women's Health K12

PROJECT SUMMARY
Advancing personalized medicine requires the study of women's health encompassing female-specific condi-
tions, such as adverse reproductive outcomes, endometriosis, menopause and gynecological cancers, as well
as disorders that clearly differ in prevalence, etiology and natural history between sexes, such as chronic respir-
atory disease, cardiometabolic disease, and neuropsychiatric disorders. The underlying pathogenesis of multi-
factorial disorders with variable onset across the lifespan reflect development-specific exposures/experiences,
at both the individual- and broader community-level, and individual response to these factors. Programming of
health outcomes results from environment-induced shifts in a host of integrated molecular, cellular, and physio-
logical states against a genetic background with innumerable social and chemical, nutritional, and microbial
exposures modulating these mechanisms. Moreover, sex-specific biology further modulate disease trajectories
over the lifespan. Given the cross-disciplinary contributing factors, addressing women's health will require
transdisciplinary (TD) team-based science training that integrates and extends beyond discipline-specific
concepts, approaches, and methods. Life course science underscores the relative importance of exposures dur-
ing different life stages in relation to health, with exposure(s) within vulnerable windows having more significant
and lasting effects on health than those outside these windows. Although much focus has been on the in
utero and early childhood periods in disease programming, other life stages including adolescence (puberty),
pregnancy, and the menopause transition, need to be considered as vulnerable windows during which future
women's health potential is programmed or shifted. These complexities underscore the need to conduct studies
addressing both susceptibility windows and the importance of coincident exposures to elucidate disease mani-
festations. The exposome concept addresses such complexities as it frames the study of the effects of all health-
relevant environmental factors over the life course using both targeted and untargeted (omics-scale) discovery
approaches. In light of the institutional investments, established infrastructure and resources, as well as men-
tored training track record summarized herein, Mount Sinai Life-course, Exposomics, and Analytic Program
(LEAP) in Women's Health K12 is uniquely poised to constitute a unique training ecosystem for women's health
scholars focused on developing transdisciplinary (TD) competencies and foundational principles in life course
theory, exposure science and environmental epidemiology, and data science - all key components of exposomics
- to address current research and training gaps in women's health. Proposed initiatives will be facilitated through
the LEAP Core with centralized resources and scientific expertise that establishes a knowledge base serving to
accelerate training in cutting-edge research that more comprehensibly considers environmental influences on
women's health across the life-course.

Public health relevance
PROJECT NARRATIVE For all of the advances we have made in medicine and science, we have seen little improvement in women's health. Many conditions that burden women either have suboptimal therapies or ineffective treatments due in part to a profound gap in knowledge regarding the environmental influences and underlying biology that drives sexually-dimorphic health outcomes across the lifespan. The Mount Sinai K12 Life-course, Exposomics, and Analytic Program (LEAP) in Women's Health training initiative will develop transdisciplinary scientists integrating life course theory, environmental sciences, data science, and translational sex-specific biology to begin to address these gaps and advance women's health across the lifespan.